Transcriptional Regulatory Mechanisms of Salivary Gland Branching Morphogenesis

Project Summary
During embryonic development, the delicate balance between proliferation and differentiation of
stem/progenitor (SP) cells of the salivary gland must be tightly regulated to maintain a homeostatic balance,
which is critical for normal tissue development and regeneration. Therefore, a better understanding of the
regulatory mechanisms driving SP cell function will provide fundamental insights into salivary gland
morphogenesis and help identify pathways that are critical for tissue regeneration following injury, damage, or
during diseased states. The transcription factor p63, specifically the ΔNp63 isoform, is highly expressed in the
SP cell populations of epithelial rich tissues including those of the skin and glandular organs such as the salivary
gland (SG). The critical importance of p63 in the SG is highlighted by the dramatic phenotype of p63-null mice,
which display a complete block in tissue morphogenesis. Although some aspects of p63 function in SG
development have been reported, our current knowledge regarding the role of p63 in the early developmental
stages of SG morphogenesis and differentiation, including branching morphogenesis, is rather limited. In
particular, the molecular mechanisms through which p63 dictates cell fate decisions and how it controls specific
gene expression programs during early SG branching, is lacking. Therefore, identifying the ΔNp63-driven
regulatory networks, particularly in the context of branching morphogenesis, will serve as an essential first step
in our understanding of SG stem/progenitor cell biology with the long-term goals of developing new strategies
for regeneration and for re-engineering the complex branching architecture of epithelial rich organs like the SG.
To address these knowledge gaps, we will utilize mouse models and sophisticated genomic approaches to study
three independent areas of interest. First, we will use conditional knockout mouse models to determine the role
of ΔNp63 in salivary gland branching morphogenesis (Aim1). Such studies are much needed as they will identify
for the first time, the functional role of p63 in SG branching morphogenesis. Second, we will perform mechanistic
studies to identify critical target genes and pathways that are governed by ΔNp63 and determine how the loss
of ΔNp63 alters the global gene expression program and affects cell fate trajectories during branching
morphogenesis at single cell resolution (Aim2). Finally, we will utilize ex vivo tissue explants to examine the role
of the WNT signaling pathway, and specifically Sfrp1, in mediating the function of ΔNp63 and test whether Sfrp1
is able to restore the branching defects observed upon the loss of p63. Collectively, these studies have the
potential to further our understanding of the ΔNp63-dependent transcriptional and cellular networks important
for the biological function of the SG particularly as it pertains to branching. Advances in our understanding of the
underlying mechanisms driving SG branching and development can provide a paradigm for regeneration of both
mouse and human SGs and better inform therapies to treat patients with developmental dysfunctions and
diseases of the SG.

Public health relevance
Project Narrative The development, differentiation and functional maturation of the salivary gland is a tightly regulated process that requires the coordinated activity of important transcriptional networks and signaling pathways. This application focuses on examining the gene-regulatory mechanisms, and in particular the role of the master transcription factor p63, in directing branching morphogenesis, cellular identity and fate. Such studies will lead to an improved understanding of the inner workings of the salivary gland and can provide molecular insights into regeneration processes that can help patients with salivary gland dysfunction.